MFRPS Maintenance, California Department of Public Health

Flexible Funding Model-Infrastructure Development and Maintenance for
State Manufactured Food Regulatory Programs
Project Summary/Abstract
The mission of the California Department of Public Health (CDPH), Food and Drug Branch (FDB)
food safety program is to ensure the safety of the food supply through effective prevention,
intervention, and response programs. As a means of accomplishing this mission, FDB has
developed strong regulatory inspection, compliance, and enforcement programs, and industry
education, outreach, and training programs.
The primary objective of our proposal is to continue maintenance of California’s best practices for
a high-quality regulatory program to enhance food safety. This entails continued interagency
collaboration, cooperation, and communication; maintenance and sustainment of conformance
with the Manufactured Food Regulatory Program Standards (MFRPS); and continued
strengthening of partnerships, coordination, and interactions with the U.S. Food and Drug
Administration (FDA) and other states’ food safety programs.
Under this proposal, we are requesting $1,350,000 in grant funds for each of the next three years
(per year: $350,000 supporting MFRPS maintenance, and $100,000 supporting dietary
supplement program development). Authorized grant funds will be used to improve and augment
current food safety program capabilities and maintain the necessary infrastructure to continue
sustainment of MFRPS.
Under MFRPS, one dedicated staff member will work as the MFRPS coordinator to maintain the
FDB food safety program’s ability to conduct high-quality inspections and investigations to reduce
the incidence of food contamination and ultimately foodborne illness associated with products
manufactured and distributed within California. Additionally, resources will be dedicated to the
development of a high-quality dietary supplement regulatory program designed to ensure that
manufacturers and distributors of dietary supplements and dietary ingredients are prohibited from
marketing products that are adulterated or misbranded.
Grant monies will enable the FDB food safety program to improve, augment, and continue its food
regulatory program through training and development of staff to increase skills and expertise;
maintain efficiency and effectiveness of critical resources; maintain information sharing among
federal, state, and local agencies; maintain succession planning; and sustain full conformance
with MFRPS and development of a comprehensive dietary supplement program. California is the
nation’s top agricultural producing state. California’s activities are essential to the success of a
nationally integrated food safety system.

Public health relevance
Flexible Funding Model-Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs Project Narrative The goals of the proposed project are to continue maintenance of California’s best practices for a high-quality regulatory program and augment inspection and investigation activities governing manufacturers and distributors of dietary supplements and dietary ingredients. These activities are intended to further enhance the State’s food safety program and align it with a national integrated food safety system. Achieving these goals will ultimately protect and improve the health of the public by assuring that food commodities, including dietary supplements, are safe, wholesome and are not adulterated.